A pilot study of fecal microbiota transplantation for Chronic Granulomatous Disorder Associated Colitis (CGD-AC)

During the fiscal year 2023, the clinical trial started enrollment after all approvals were obtained (National Institutes of Health Institutional Review Board #000809 and U.S. Food and Drug Administration Investigational New Drug application #28209). Three subjects with Chronic Granulomatous Disease associated colitis have successfully received fecal microbiota transplantation. Two subjects have completed the trial to date. Safety monitoring committee meetings have been held every 6 months. The trial will continue to enroll during the fiscal year 2024.